Community Engagement Core

SUMMARY: COMMUNITY ENGAGEMENT CORE
The CEC serves as the information and communications nexus for the GC-CPEH. Our overall goal is to assist
the communities we serve in achieving a healthy environment through by actively engaging community partners.
Our Vision is to foster healthy communities by increasing communication and building collaborative relationships
to implement research and programming responsive to community needs; develop, adapt, and share innovative
strategies for engagement; and improve use of scientific findings to deepen understanding of environmental
health issues affecting the greater Houston area and the Gulf Coast Region. Specific Aims to achieve this
Vision are: Aim 1: Engage community partners through multi-modal communication strategies that
identify community needs, inform Center directions and research, and establish avenues for disseminating
relevant environmental health sciences (EHS) to collaborators (research to impact). Specific Aim 2: Advance
the fields of community engagement and environmental health communication through innovative strategies and
mechanisms. Specific Aim 3: Translate and disseminate EHS to improve understanding of environmental health
and strengthen the ability of individuals and organizations to make informed decisions related to environmental
health. Activities focus on multi-modal communications, translating and disseminating EHS for our communities,
rigorously evaluating program effectiveness, and sharing best practices. CEC collaborators include Center
leaders and members, and targeted audiences comprising community members, including Veterans and those
engaged in EHS decision-making. We aim to broaden participation across all areas of the Center’s work. The
CEC uses multiple strategies to engage partners and connect with a wide variety of audiences. SCI Café (where
Science and Communities Interact) provides a venue for research translation through informal dialogues among
scientists and community members. Additional gatherings of community members and Center investigators
provide opportunities for open dialogue and mutual learning, helping to identify emerging environmental health
concerns that have guided the Center's research responsive to community needs. A vital Community Advisory
Board (CAB) informs Center science and provides a mechanism for communication between our investigators
and our extensive network of community partners.